Repression via Facultative Heterochromatin

Project Summary
A critical question in the field of Epigenetics/Mammalian Gene Regulation is how a cellular identity is inherited
by progeny cells during cell division. This fundamental aspect of epigenetic regulation was recently clarified in
our lab: repressed, but not active, chromatin domains are inherited. Repressed chromatin domains in facultative
heterochromatin are maintained by the multi-subunit complex, Polycomb Repressive Complex 2 (PRC2), that
catalyzes the histone post-translational modification, H3K27me3. PRC2 exhibits a notable “read and write”
feature whereby its recognition of H3K27me3 results in its allosteric activation. Thus, PRC2 can fully restore
repressive chromatin domains upon inheritance of H3K27me3-nucleosomes. Remarkably, our findings point to
a previously reported histone chaperone, NPM1, as facilitating this inheritance of repressed chromatin: NPM1 is
exclusively localized to chromatin in late S-phase when repressed chromatin is replicated, and interacts directly
with PRC2. Our latest findings demonstrated specific de-repression of PRC2-regulated genes upon auxin-
mediated depletion of NPM1 during S-phase of the cell cycle. We will expand our mechanistic studies of
epigenetic inheritance by investigating the role of NPM1 as an S-phase-specific histone chaperone and its
interplay with PRC2 in a series of histone chaperone assays performed in vitro with distinct candidate
oligonucleosomal templates. We will investigate the role of NPM1 in epigenetic inheritance by adapting our in
vivo assay for chromatin domain inheritance as a function of the presence of NPM1 and pertinent NPM1 mutants.
The interactive dynamics of NPM1 and PRC2 in the context of a replication fork is critical information towards
understanding the transfer of parental nucleosomes to daughter DNA strands. Thus, single-molecule localization
microscopy as well as stochastic optical reconstruction microscopy (STORM) are expected to bear directly on
the role of NPM1 and the significance of its interaction with the epigenetic regulator, PRC2. Importantly, mutant
NPM1c associated with ~35% of all Acute Myelogenous Leukemia (AML) is mis-localized to the cytoplasm. We
propose that NPM1c hampers normal PRC2 function. Indeed, similar to our findings above upon NPM1
depletion, known HOX gene targets of PRC2 are aberrantly expressed in NPM1c AML, participating in the
establishment of the leukemic state. Deposition of H3K27me3 by PRC2 and DNA methylation by DNMT3A result
in repressed chromatin, but are usually mutually exclusive. Yet, NPM1 and DNMT3A mutations synergize in
leukemogenesis. Thus, we further propose that DNMT3A partially compensates for our proposed NPM1c-
mediated thwarting of PRC2⏤which is lost upon DNMT3A mutation. Through temporal expression of NPM1c as
a function of the presence of mutant DNMT3A, we will track the repercussions to gene expression, features of
repressed chromatin domains, PRC2 chromatin occupancy and DNA methylation in both tissue culture and a
mouse model of AML to fully grasp the sequence of aberrant epigenetic events as they occur in leukemogenesis.

Public health relevance
Project Narrative The inheritance of a particular gene expression profile is key to conveying proper cellular identity to progeny cells upon cell division. The proposed studies will directly expose key mechanistic aspects and biologically relevant factors inherent to this epigenetic regulation, as well as the sequence of events that accompany leukemogenesis as a consequence of naturally occurring mutations that target this inheritance.